Editing basal cells for durable gene therapy of cystic fibrosis

Project Summary
Cystic fibrosis (CF) patients with nonsense mutations of the disease-causing CF transmembrane conductance
regulator gene (CFTR) cannot benefit from existing small molecule therapies and need gene therapy of the
CFTR mutation to restore any function and ultimately, for a cure. Since 95% of CF-associated comorbidities
affect the respiratory tract, pulmonary administration of gene therapies would be advantageous, as it would
increase the therapeutic index by significantly increasing dosing 10- to 20-fold without incurring the off-tissue
toxicity seen with systemic administration. For inhalation gene therapy, the gene delivery systems must possess
the physicochemical properties to overcome the transport barriers, such as mucus and reach the target cells in
the airways at therapeutic concentrations. However, current approaches in the clinic would need repeated dosing
since they do not target the basal cells, or the airway stem cells, for one-time, permanent correction. Also, gene
therapy approaches currently in clinical trials do not fix the mutation but provide a corrected CFTR copy, whereby
the therapeutic benefit is temporary. To address these challenges, it would be desirable to develop nucleic acid
delivery systems that can reach the airway basal cells and fix the CFTR mutation towards permanent correction
of lung CF disease. Here, we will develop peptide surface-functionalized lipid nanoparticles (pepLNPs) for
pulmonary delivery that can reach the basal cells in vivo and deliver base editors in relevant cell culture and
animal models to precisely edit and correct specific G542X and G553X nonsense mutations present in CF.
Previously, we have identified peptide ligands that can penetrate through the mucus barrier present in CF and
in preliminary evidence, demonstrate that these pepLNPs, can reach and achieve editing in the basal cells.
Leveraging our platform technology, we propose to make pepLNP formulations that can stably encapsulate,
protect, and deliver mRNA encoding base editing components, to reach, and edit basal cells in vitro and in vivo.
Importantly, we will elucidate how these pepLNPs penetrate through the mucus barrier and are taken up by basal
cells. Finally, we will validate that upon delivery to the basal cells, pepLNPs will deliver adenine base editors to
correct the genotype and restore functional phenotype of cells that had possessed the previously undruggable
nonsense CFTR mutations. This proposed work can have a transformative impact, as it aims to achieve one-
time, “permanent” correction for durable gene therapy of CF by targeting the basal cells and specifically fixing
the inherent CFTR mutation. While this strategy focuses on CF, in the long-term, this strategy can transform
treatment of many genetic diseases needing permanent correction.

Public health relevance
Project Narrative Here, this proposal is relevant to public health because it seeks to develop lipid nanoparticles that protect therapeutic nucleic acids and overcome the mucus and cellular barriers to deliver therapeutic nucleic acids that correct mutations towards treatment of genetic disease cystic fibrosis for durable therapy. The proposed work is relevant to part of the NIH’s mission to help further understanding biological systems and leveraging that knowledge to improve health and reduce illness.